The Role of Sex-Hormones in Anal Human Papilloma Virus Persistence (HPV) and Systemic and Mucosal Immunity in people with or at risk for HIV

Modified Project Summary/Abstract Section
People with or at risk for HIV are disproportionately affected by anal high-risk human
papillomavirus (HR-HPV). HIV alters HPV immunity and potentiates HPV persistence, thus
increasing cancer risk. The peripheral and mucosal immune response against anal HPV is
linked to the regression of high-grade anal dysplasia – the precursor to anal cancer. In women,
estrogen may alter the immune response against HPV-infected cells, increase HPV persistence,
and facilitate the progression to cervical cancer. In men, higher testosterone levels have been
linked to a higher prevalence of anal HPV. However, there is a critical gap in understanding the
effect of sex-steroids on HPV immunity and persistence, and consequentially the progression to
anal dysplasia, particularly in people with or at risk for HIV. This gap hinders the research into
urgently needed novel HPV immunotherapies targeting anal dysplasia in these populations.
We will conduct a secondary analysis of samples from our HPV natural history cohorts. In one
of these cohorts, of 80 people in Washington DC, we found a high prevalence of HR-HPV (73%)
and anal dysplasia (48%). In Aim 1, we will assess the effect of estradiol or testosterone
blockers (ETB) on systemic HPV16 immunity using flow cytometry. We will compare, crosssectionally in people with natural infection (1a) and longitudinally in response to the HPV 9-
valent vaccine (1b), immune markers, the proportion of peripheral HPV-specific CD4 T-cells,
and L1-specific antibodies (1a and 1b), and CD8 T-cells (1a), between 60 people with high
levels of estradiol and low levels of testosterone and 60 with low levels of estradiol and high
levels of testosterone, stratified by HIV status.
In Aim 2, we will assess the effect of ETB on the mucosal HPV16 immune response. Using
confocal microscopy on anal tissue of participants with anal HPV16 infection, we will compare
quantitative and qualitative characteristics of immune cells from 40 people with high levels of
estradiol and low levels of testosterone and 40 with low levels of estradiol and high levels of
testosterone, stratified by HIV status and lesion type. In Aim 3, we will examine the effect of
ETB on anal HR-HPV persistence defined as the detection, on HPV whole-genome sequencing
(NGS), of the same HR-HPV sublineage at an initial timepoint and at 6, 12, and 18-months. We
will compare HPV persistence between 60 people with high levels of estradiol and low levels of
testosterone and 60 with low levels of estradiol and high levels of testosterone, stratified by HIV
status.
The proposed work will provide training in sex-steroids biology, interpreting results of HPV NGS
and immunological techniques, and academic skills needed for a career in translational clinical
research under the mentorship of Drs. Gaykalova, Kottilil, Klein, Lisco, and Rosenthal. This data
will inform shared decision-making discussions based on hormone levels, provide guidance for
optimal anal cancer screening and treatment of anal dysplasia in people with or at risk for HIV,
and guide the study of HPV immunotherapies for anal dysplasia by explaining the role of sex-steroids on immunological and virological research endpoints.

Public health relevance
Modified Public Health Relevance Section Anal cancer is due to persistent Human Papilloma Virus (HPV) infection and disproportionately impacts people with or at risk for HIV. Researchers do not understand the effect of sex hormones (estrogen and testosterone) on the immunity against HPV and HPV’s persistence in the anus – both factors that affect anal cancer. This proposal aims to understand the effect of these hormones on the immune response against HPV and HPV persistence in the anus with the goal of guiding anal cancer prevention strategies and develop future immunology based anal cancer therapies for this purpose.